Aging specific gene expression in Drosophila

DESCRIPTION (provided by applicant): The long-term goal of this research is to understand the regulation of gene expression during aging using the model organism Drosophila melanogaster. Aging in both flies and humans is found to be associated with a tissue-specific induction of oxidative stress response genes, including members of the hsp70 family and hsp22 (alpha-crystallin) family. Heat shock proteins (hsps) are induced in all species in response to heat and other stresses. hsps appear to be involved in prevention and repair of protein damage and can confer increased heat and oxidative stress resistance to many cell types. Drosophila hsp70 and hsp22 genes are induced in a characteristic, tissue-specific pattern during aging. This aging-associated upregulation involves both transcriptional and posttranscriptional mechanisms, and appears to be in part a response to oxidative stress. hsp22 exhibits one of the largest aging-related increases known for a eukaryotic protein (>150-fold). Homologs of hsp70 and hsp22 are upregulated in humans during normal aging and in numerous pathophysiological and aging-related disease states. We hypothesize that altered hsp gene expression is a species-general biomarker of aging and results from a breakdown in normal nuclear-mitochondrial signaling. We propose to study the aging-related transcriptional regulation of Drosophila hsp70 and hsp22 in detail. The research involves genetic and transgenic manipulation of gene expression and life span in Drosophila. The experiments will test several specific hypotheses relating aging and hsp gene expression. The metabolism and detoxification/repair of cells is coordinated across tissues, occurs in diurnal (24 hour or circadian) cycles, and involves hsp and Phase I/II gene products similar to those implicated in life span extension downstream of the C. elegans insulin-like signaling pathway. Our preliminary data suggests a model in which mitochondrial MnSOD and retrograde ROS (H2O2) signaling coordinately regulates hsp22 and Phase I/II gene expression, metabolic cycles and life span. We have also implicated the tumor suppressor p53 and the sex-determination pathway in the regulation of hsp22 expression during aging. The dynamic nature of these processes requires that we assay fly aging and gene expression longitudinally to address basic mechanisms. We have developed novel 3D video technology to facilitate longitudinal assay of cyclical gene expression patterns during aging. PUBLIC HEALTH RELEVANCE: In humans and in the model research organism Drosophila, aging is associated with the expression of oxidative stress-response genes. For example, heat shock protein genes such as hsp70 and hsp22 are induced in tissue-specific patterns that are similar between humans and flies, and the level of hsp gene expression correlates with life span in both humans and flies. By studying gene expression in aging Drosophila, we hope to better understand the basic mechanisms of aging, and to ultimately develop interventions for human aging-related diseases.

Public health relevance
Project Narrative In humans and in the model research organism Drosophila, aging is associated with the expression of oxidative stress-response genes. For example heat shock protein genes such as hsp70 and hsp22 are induced in tissue-specific patterns that are similar between humans and flies, and the level of hsp gene expression correlates with life span in both humans and flies. By studying gene expression in aging Drosophila we hope to better understand the basic mechanisms of aging, and to ultimately develop interventions for human aging-related diseases.